A Randomized Phase II Trial of Flibanserin in Men Receiving Androgen Suppression for Prostate Cancer

PROJECT SUMMARY
Androgen deprivation therapy (ADT) is used to improve survival for men with metastatic and high risk
localized prostate cancer. Unfortunately, ADT is also associated with a number of adverse effects, and sexual
dysfunction occurs in nearly all men who receive this treatment. Sexual dysfunction is the most common
complaint among men with prostate cancer and contributes to worse quality of life (QoL). The loss of sexual
interest, in particular, is highly distressing for men with prostate cancer and their partners, which contributes
additional psychological morbidity in these patients. Despite the importance of sexual health in men with prostate
cancer, previous interventions to improve sexual interest in men receiving ADT have had little success, and new
strategies are needed. We hypothesize that flibanserin can be used to increase sexual desire among men
receiving ADT for prostate cancer. Flibanserin is a multifunctional serotonin receptor agonist/antagonist that acts
as an agonist of post-synaptic 5-HT(1A) receptors and an antagonist of 5-HT(2A) receptors, that has previously
been approved to treat hypoactive sexual desire disorder in women. In this proposal, we will conduct a double
blind, placebo controlled, randomized phase II clinical trial to assess the efficacy and safety of flibanserin 100mg
daily among men receiving ADT for prostate cancer. We will recruit 50 men with prostate cancer who are
receiving ADT and also endorse reduced sexual interest to participate. Men will be randomized to receive either
daily flibanserin 100mg or placebo for a 12-week period. Patient-reported frequency of attempted sexual
intercourse, sexual QoL, global QoL, and toxicity will be assessed at baseline and at pre-specified time points.
Specific Aim 1 will assess the efficacy of flibanserin. The frequency of attempted sexual intercourse among
men receiving flibanserin will be compared to men receiving placebo. The change in patient reported sexual QoL
will also be compared between the study groups. Specific Aim 2 will assess the safety and tolerance of
flibanserin. The frequency of grade 3+ adverse events and study drug discontinuation among men receiving
flibanserin will be reported. The frequency of grade 2+ and grade 3+ patient reported adverse events will be
compared between the flibanserin and placebo groups. Accomplishing these specific aims will provide us with a
preliminary understanding about use of flibanserin in men receiving ADT for prostate cancer. This study will be
conducted by a qualified multidisciplinary team of investigators with experience in both clinical trials and cancer
survivorship research at the University of Alabama at Birmingham O’Neal Comprehensive Cancer Center. The
results of this clinical trial will be used to inform the design of a phase III clinical trial. Our long-term goal is to
develop an evidence based treatment strategy that will significantly improve sexual health and QoL for prostate
cancer survivors.

Public health relevance
PROJECT NARRATIVE Most men receiving androgen deprivation therapy for prostate cancer have reduced sexual interest, which is highly distressing for men with prostate cancer and contributes to worse quality of life. This study is a double blind, placebo controlled, randomized phase II clinical trial to assess the efficacy of flibanserin 100mg daily to increase sexual interest among men receiving androgen deprivation therapy for prostate cancer. Results from this study will be used to inform the design of a phase III clinical trial and support our long-term goal of developing an evidence based treatment strategy that will significantly improve sexual health and quality of life for prostate cancer survivors.